Phenotyping and Environmental Modifier Facility Core

Project Summary
Our Phenotyping and Environmental Modifier Facility Core (PEMFC) organizes Mount Sinai's extensive
existing environmental epidemiology, clinical, psychometric, analytic and technical expertise as a key Center
resource. The PEMFC helped catalyze the remarkable growth in environmental health research over the first 3
years of our Center linking environmental exposure and their modifiers to measures of health and
development. The PEMFC provides Center Members access to expertise and state-of-the-art equipment
necessary for clinical phenotyping and quantification of health and developmental outcomes across the
lifespan as well as the measurement of modifiers of chemical environmental toxins.
The PEMFC provides
clinical, technical and scientific input to enhance the selection of age-appropriate valid, reliable and time
effective low burden instruments to measure
health and disease across the lifespan with particular focus on
critical periods (pregnancy, infancy, early childhood, adolescence)
. This includes Center supported space and
phenotyping equipment covering target priority areas identified to date (neurodevelopment/behavior, obesity,
asthma, allergy, endocrine, renal and cardiovascular phenotypes).
The Core also facilitates translational
research aimed toward more fully elucidating the impacts of key interactions between chemical toxicants and
environmental modifiers across development, specifically psychological stress and other social determinants
as well as nutrition. Given that exposure to chemical and non-chemical toxicants as well as nutritional status
often track together along socioeconomic gradients, a related focus will be the multi-faceted elucidation of
mechanisms underlying the health disparities observed in our local communities and more globally. The
scope of responsibility for the PEMFC includes: 1) maintaining and providing access to adult and pediatric
health assessments that include self-reports, observational data, and performance based measures; 2)
assisting Center Members with rigorous and appropriate protocols to use when applying such measures in
research studies; 3) advising on data analysis that includes psychometric analyses including the use of
multiple phenotypes in a phenomic or true multivariate analysis; and 5) integrating environmental health with
precision medicine initiatives at Mount Sinai.
The PEMFC curates measures identified by our expert faculty
together with the information needed to implement the measures including a summary of the psychometrics
and detailed protocol(s) for data collection, scoring procedures, and incorporation into analyses. PEMFC
faculty have particular expertise to guide selection of measures that
can be characterized through a common
standardized metric
in order to facilitate
data sharing, interoperability and harmonization to catalyze
opportunities for Center Members to participate in collaborative multi-site studies. PEMFC faculty will also work
with our clinical colleagues to integrate environmental health data with electronic health record data to catalyze
environmental health translational research across the Mount Sinai Health System.